Spatiotemporal mapping and engineering in the dark proteome

The overview of the lab is that we investigate how protein motions associated with intrinsic disorder have specific
functions. We use a range of methods including NMR, small angle scattering(SAS), and affinity measurements combined
with extensive simulation of processes at atomistic or coarse-grained levels. We collaborate extensively to gain insight
into a broad set of functions, while maintaining specific expertise. Our current studies are mainly focused (a) on the
role of disorder of proteins lining the central transporter of the nuclear pore complex (NPC) which facilitate transport of
a select group of biomolecules, mainly proteins into the nucleus, and RNA out, while keeping out others, and (b) on how
to engineer triggered production of proteins in specific contexts using inteins. For the NPC, integrative structural
biologists have provided a detailed picture of the framework ring structure mainly by cryo EM, and starting with that, a
coarse-grained model of the central transporter was developed based on simulation and SAS, with simplified
representation of the diffusing molecules and of the flexible internal proteins. The enthalpies and entropies of
interactions between the passive (slow) diffusers, and facilitated diffusers with the internal proteins was obtained by
experiments on isolated components and provides rates of motion for the model. Running the model with various
different sizes of passive and facilitated diffusers provides a map of particles, and their rates of diffusion can be obtained
and analyzed as an energy of activation required for passage through the entropic barrier of the internal proteins and
interacting diffusers. Our first map provides a clear picture that discriminates the size dependence of the passive and
facilitated diffusers. The weak, rapid interactions between facilitated diffusers and internal flexible proteins balances
out the entropic exclusion from flexibility. This first map averages out all the different flexible proteins in the central
transporter, and does not have a precise externally derived time scale, and our next steps will provide those details by
production of synthetic pore models based on DNA origami, to characterize both strengths of interactions of the various
flexible proteins and their interactions with diffusers, and provide an improved time scale by appropriate NMR
measurements on isotopically labeled proteins. Advancing our description of NPC transport likely increases our
understanding of malfunctioning NPC’s roles in cancer, ageing, viral infection, and neurodegeneration.
Inteins are the proteins responsible for protein splicing, a posttranslational modification where intervening proteins
(inteins) self-excise from the precursor and ligate the external sequences (exteins). This makes them excellent tools for
protein engineering, using split inteins with two segments associating. One of the two segments is usually significantly
disordered. We seek to expand the application of inteins to provide conditional proximity splicing by detailed analysis
of the structural and dynamic features of modified split inteins. This requires engineered constructs with zero mutual
association (and splicing) without trigger activation, but which turn on when triggered. We shall use the experimental
and simulation tools to develop this significant application for biomedical research and potential for therapeutics e. g.
triggered dual antibodies or drug conjugates at specific cell sites.

Public health relevance
We investigate how protein motions associated with intrinsic disorder have specific functions. These play important roles in cancer, ageing, viral infection, and neurodegeneration. We develop ways of engineering proteins at specific times and places for possible diagnostic and therapeutic use.